Mycobacterium avium complex pulmonary infection: immunologic and transcriptomic signatures of disease and treatment response

PROJECT SUMMARY/ABSTRACT
We seek to define immunologic and transcriptomic signatures of Mycobacterium avium complex (MAC)
pulmonary disease and microbiologic treatment response. Nontuberculous mycobacteria (NTM) are
environmental pathogens that is present in the soil and water. MAC is the most common cause of NTM
pulmonary disease, causing chronic, debilitating disease in predominantly older patients with underlying lung
disease. Prior work has illustrated that incidence rates of MAC pulmonary disease are increasing substantially,
particularly among women. Currently, the role of the host response in the development of disease is not well
described. Treatment, when necessary, consists of 3-4 antibiotics for 18+ months. There is an urgent need to fill
the critical gaps in knowledge of factors associated with disease burden and treatment response. Our lack of
understanding poses significant diagnostic and therapeutic challenges. First, it is often difficult to discern
colonization vs. disease caused by these organisms, and second it is difficult to predict who will benefit from
therapy, or who will remain disease-free after therapy completion. There is a need for non-invasive biomarkers
of disease burden and treatment response, to limit exposure to computed tomography scan radiation that is
currently used to monitor disease along with acid-fast sputum culture and patient-reported symptoms. Based on
M. tuberculosis literature coupled with observations of NTM disease in the setting of anti-tumor necrosis factor
therapy, the Th1 response could explain NTM pulmonary disease pathogenesis in some patients.
This prospective biobank enrolls patients in a sub-study of our ongoing MAC2v3 pragmatic clinical trial, as well
as others who meet American Thoracic Society/Infectious Disease Society of America clinical, radiographic, and
microbiologic disease criteria and are starting treatment for MAC pulmonary disease. This builds on our existing
NTM Clinical Trials Network infrastructure and extensive experience developing and managing the Northwest
NTM Biobank. The Biobank has supported collaborations between MPIs Drs. Winthrop and Lewinsohn to
conduct preliminary feasibility studies of immune correlates of disease. MPIs Drs. Lewinsohn and McWeeney
have a longstanding history of collaboration. During Years 1-4, we will collect blood and sputum samples
longitudinally from patients initiating treatment for MAC pulmonary disease and conduct Aims 1A and 2A. During
Years 3-5 we will complete Aims 1 and 2. In this setting we will conduct high throughput cytometry time-of-flight
(CyTOF) analysis of peripheral blood mononuclear cells to identify an immune signature of disease and
microbiologic treatment response. Similarly, we will conduct whole blood next generation RNA sequencing to
identify an RNA transcriptome signature of disease and microbiologic treatment response. Ultimately, the
development of a disease signature and biomarkers predictive of treatment response could help better guide
therapeutic and diagnostic decision-making with regard to MAC pulmonary disease.

Public health relevance
PROJECT NARRATIVE Chronic Mycobacterium avium complex (MAC) pulmonary disease is an increasingly common orphan disease that causes progressive disability in older adults. Diagnosis is challenging and often delayed, and there is a tremendous unmet therapeutic need. We seek to define immunologic and transcriptomic signatures of MAC pulmonary disease that could ultimately be used to improve diagnosis, clinical management, and design of clinical trials of new and repurposed therapeutics.